Insular cortex-BNST neural circuit regulation of chronic alcohol abstinence-induced negative affect

PROJECT SUMMARY/ABSTRACT
Alcohol use disorder (AUD) afflicts millions of individuals and their families each year. AUD is frequently
comorbid with anxiety and depression, indicating potential sources for the motivation to consume alcohol.
Alcoholics commonly list stressors and negative affective states as leading triggers of cravings and relapse,
and severity of the disease state correlates with relapse susceptibility. The health and financial burden
associated with AUD highlights the pressing need for more research focused on understanding the interaction
between AUD and negative affective disturbances. Identifying key neuroadaptations driving this debilitating
disease is essential for developing better diagnostic tools and treatments for affective symptoms in alcohol
abstinence. Converging evidence suggests the transition from social use to negative reinforcement-driven
alcohol seeking involves a set of brain structures collectively referred to as the extended amygdala. The bed
nucleus of the stria terminalis (BNST), a component of the extended amygdala network, is a critical node for
stress-related disorders such as anxiety, depression, and addiction. The BNST plays a prominent role in many
facets of alcohol addiction including binge drinking and cravings in withdrawal. The BNST interacts with many
cortical, subcortical, midbrain, and hindbrain regions to determine general affect. Our recent work identified a
functional connection between the insular cortex (insula) and the BNST. The insula is involved in interoceptive
awareness, cognitive control, and sensory processing, and mounting evidence suggests a role for the insula in
alcoholism and negative affective disturbances. We used a mouse model of chronic drinking followed by forced
abstinence (CDFA) to outline a definitive role for the insula-BNST pathway in abstinence-induced negative
affect, and this proposal will significantly build on this foundational evidence. We will combine in vivo calcium
fiber photometry and ex vivo electrophysiology with genetic mouse lines and a variety of sophisticated viral-
genetic techniques to isolate circuit-specific neuronal ensembles. The mentored (K99) phase will provide
training in fiber photometry and complex viral-genetic manipulation strategies to determine the functional and
physiological state of BNST neurons receiving insular inputs (Aim 1) and insular neurons that project to the
BNST (Aim 2) in the protracted abstinence phase of CDFA. The independent (R00) phase will identify 2nd order
inputs onto insulaàBNST neurons, with the goal of further delineating the complex neurocircuitry regulating
abstinence-induced negative affect. The proposed studies and related career development training plan in this
Pathway to Independence Award collectively provide the ideal mechanism to transition the applicant to a
career as an independent addiction neuroscientist. The results will significantly advance our understanding of
the neural adaptations that occur in protracted abstinence following chronic alcohol abuse.

Public health relevance
PROJECT NARRATIVE Negative affective disturbances, including stress, anxiety, and depression, are characteristic of alcohol abstinence, and a leading cause of relapse. A greater understanding of the complex neural circuitry regulating the disease state will lead to better diagnostic tools and treatment options for abstinence-induced negative affect. This project will investigate the functional state of the insular cortex-bed nucleus of the stria terminalis neural pathway in alcohol abstinence, two regions implicated in alcohol use disorders and negative affect.